Chemically Tunable Mucins to Probe Pathogenic Function in the Epithelial Milieu

Abstract
Human epithelial tissues are essential biological barriers that secrete a unique hydrogel known as mucus.
Tissues generate distinct types of mucus that provide specific biological functions like hydration, pathogen
defense, and mediating the movement substances toward the cell surface. The major component of mucus,
mucin proteins, is critical for gel structure and function. Mucins are a diverse family of 20+ proteins characterized
by a large, rod-like domain rich serine/threonine with attached saccharides, or glycans. Molecular-level mucus
studies have been challenging due to heterogeneous glycan patterns that are tissue and species specific, as
well as varied protein expression levels and splicing that result in structures with varied lengths and sequences.
Misregulation of mucin expression, splicing, and glycosylation results in altered structures that may affect
biological function with outcomes relevant to infection, inflammation, and cancer. Researchers typically utilize
mucins isolated from farm animal sources for such studies, but this source suffers from batch-to-batch variation,
structures that are not chemically defined and have non-human glycan patterns that cannot be systematically
altered. Currently, there is an unmet need for chemically-defined mucins that can be tuned at the molecular level
and possess human glycosylation patterns. Such materials are essential to probe the role of these vital
biomaterials in health and disease. The proposed research will address this critical need by developing a method
to prepare synthetic human mucins, which will be applied to probe glycan-pathogen interactions. Techniques
from carbohydrate chemistry, amino acid N-carboxyanhydride (NCA) polymerization, and enzymatic
glycosylation, will be combined to generate materials with fully tunable properties. I will generate a panel of
chemically-defined mucin glycopolypeptides with varied lengths, amino acid compositions, glycosylation
densities, and glycan structures. Structure design will be guided by published glycomic analysis of native human
mucins implicated in airway infections. All glycopolypeptides will be fully characterized for physicochemical
properties using a variety of spectroscopic, microscopic, and biochemical methods. Mucins and their glycans
have previously been shown to affect activity of pathogenic microbes such as adhesion, biofilm formation, and
virulence traits. Synthetic mucins will be applied to reveal how glycan presentation affects these pathogenic
functions. Such studies are not possible with native mucins since glycosylation cannot be controlled and is
typically not even characterized. Overall, I aim to shed light on the molecular structure-function relationship
between mucins and microbes. This interdisciplinary approach will combine techniques from multiple fields to
answer important questions about infection that cannot be undertaken by biological methods alone. The
proposed materials could have therapeutic applications as antimicrobials or in muco-replacement therapies.

Public health relevance
Project Narrative Human epithelial tissues are coated in a unique hydrogel known as mucus that provides vital biological functions like tissue hydration, pathogen defense, and mediating the movement of substances toward the cell surface. Mucus is particularly challenging to study because the primary protein component can only be isolated as a mixture of structures with varied lengths, amino acid compositions, and with a variety of attached sugars, all of which affect biological function. The proposed research aims to develop methods to reproducibly prepare chemically tunable mucus proteins and use them to shed light on the molecular structure-function relationship between mucins and pathogenic microbes.